Delivery of Nucleic Acid Therapeutics

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Delivery of Nucleic Acid Therapeutics,
organized by Drs. Daniel Siegwart and Kathryn Whitehead. The conference will be held in Banff, Alberta,
Canada from January 22-25, 2024.
This conference will bring together world-renowned experts to explore the complex science, engineering, and
application of nucleic acid delivery systems. The recent overwhelming success of mRNA-based SARS-CoV-2
vaccines has refocused attention on the potential of nucleic acids as medicines. Despite steady progress over
decades, the broad application of nucleic acid therapies relies on the development of enabling delivery systems.
This conference will highlight cutting-edge strategies to transport nucleic acids into target cells and organs
without toxicity, address the challenges of delivering nucleic acids systemically and intracellularly and emphasize
exciting clinical applications of nucleic acid delivery technologies. This conference will provide a rare opportunity
to convene experts from a broad array of disciplines, including engineering, materials science, biology,
chemistry, and medicine with a focus on nucleic acid delivery, which will facilitate stimulating conversations that
will guide future development of the field. One aspect that makes this conference completely unique is that it will
be held jointly with another Keystone Symposia meeting entitled “Precision Genome Engineering.” Through the
joint sessions, attendees will hear from leaders in the gene editing field, Drs. Jennifer Doudna and Feng Zhang,
and these and other sessions will facilitate more engagement between these aligned communities. Attendees
will leave the conference with an expanded network of colleagues, armed with a new appreciation for delivery
challenges, solutions, and applications. Ultimately, these experiences will catalyze the development and
execution of new ideas that will bring many more nucleic acid therapies to fruition.

Public health relevance
PROJECT NARRATIVE Nucleic acid therapeutics, including DNA and RNA-based drugs, have emerged as promising treatments for many diseases. Nucleic acids offer a high degree of specificity and selectivity for their targets, making them potentially safer and more effective than traditional small molecule drugs, but their delivery to specific cells and tissues remains a central challenge. This Keystone Symposia conference will assemble researchers who bring diverse scientific perspectives and methodologies to advance the field of nucleic acid therapeutics toward broader clinical applications.